Parkin tumor suppression

PROJECT SUMMARY
The loss of endogenous tumor suppressors is an obligatory step in tumor onset and progression, but the
underlying mechanisms are elusive and the breadth of their targets mostly unknown. We have now discovered
that Parkin, a mitochondria-associated E3 ubiquitin ligase biallelically altered in early-onset Parkinson’s
Disease, functions as a novel, dual mode tumor suppressor. This involves inhibition of intrinsic tumor traits of
cell motility and metabolism but also reprogramming of an antitumor immune microenvironment. In this
pathway, Parkin recruitment to mitochondria “primes” immunogenic cell death, controls the release of Damage-
Associated Molecular Pattern (DAMP), and activates kinase cascades for transcription of interferon genes and
inflammatory cytokines, independently of mitophagy. The result is enhanced intratumoral infiltration of CD8+ T
cells, reduced myeloid immunosuppression, and inhibition of primary and metastatic tumor growth. Because
Parkin is epigenetically silenced in all human cancers, dual mode tumor suppression is a universal barrier
against malignancy. Therefore, the hypothesis that Parkin tumor suppression bridges mitochondrial
activation of interferon signaling to immune reprogramming of the microenvironment can be
formulated and will constitute the focus of the present application. Three complementary and
multidisciplinary specific aims will elucidate the role of Parkin innate immunity in tumor suppression. In the first
specific aim, we will characterize how Parkin “primes” immunogenic cell death, elucidate the role of ER stress
and autophagy in mitochondrial necroptosis, and map the cellular and biochemical requirements of DAMP
release. The second specific aim will dissect the signaling requirements of Parkin activation of innate immunity
with respect to cytosolic cGAS-STING and inflammasome activation, mitochondrial RIG-I-MAVS sensing and
assembly of a STAT1-regulated ISGF3 transcriptional complex for T cell activation and dendritic cell function.
In the third specific aim, we will test the impact of Parkin innate immunity in preclinical orthotopic and
transgenic models of primary and metastatic tumor growth, in vivo, modulation of antitumor vaccination
strategies, and differential sensitivity to conventional and immune therapies. The application builds on
expansive preliminary data, a novel concept of dual mode Parkin tumor suppression, and the redirection of
mitochondrial innate immunity, previously known in viral infections, for antitumor responses. The results may
be practice changing. As proposed here, the elucidation of Parkin innate immunity will identify new strategies
to restore an antitumor immune microenvironment, dampen myeloid immunosuppression and enable broader,
more durable patient responses to conventional and immune therapy, including in late-stage disease.

Public health relevance
PROJECT NARRATIVE The loss of endogenous tumor suppression is an obligatory step towards cancer, but the mechanisms are elusive. We have now discovered that Parkin, a molecule altered in early-onset Parkinson’s disease, functions as a unique dual mode tumor suppressor, inhibiting intrinsic tumor traits of cell motility and metabolism while also reprogramming an antitumor immune microenvironment. This pathway involves Parkin “priming” of immunogenic cell death, control of cytosolic and mitochondrial danger-sensing pathways and transcriptional activation of interferon gene expression. The proposed studies will elucidate the cellular and molecular requirements of Parkin innate immunity in cancer and uncover novel strategies to improve the response to immunotherapy in advanced disease patients.